Research Education Component

The overarching objective of the Research Education Component (REC) is to continue to provide a carefully
structured curriculum and comprehensive and innovative mentoring leading to enduring careers of under-
represented investigators in Alzheimer’s disease (AD) and AD-related dementias (ADRD) research focusing on
health equity and consideration of social factors, health system factors, and structural racism across the life
course. Our renewal application supports mentoring JHAD-RCMAR Scientists’ research encompassing the
epidemiology of dementia and development, testing, and implementation of novel interventions for diverse
minority older adults and care providers to enhance health and functioning. Mentoring relationships include
early-career researchers and/or mid-career scientists newly transitioning into AD/ADRD research focusing on
minority aging. The REC leverages infrastructure and advanced mentoring practices that focus on health
disparities and health equity, cognitive decline, AD/ADRD, and minority aging within and across Johns Hopkins
centers, as well as relevant faculty and resources at Morgan State University and Hampton University. We set
out a plan to assure successful mentoring of, and collaboration with, diverse researchers pursuing careers in
the focused area of this AD-RCMAR: novel approaches to enhance and maintain cognitive health and function
and reduce AD/ADRD dementia risk among minority older adults. Our REC is structured to mentor JHAD-
RCMAR Scientists to be successful with developing and carrying out pilot projects and includes structured
longitudinal mentorship for RCMAR Scientists, which will support independent, NIA-funded research careers
focused on health disparities and AD/ADRD research among older adults, particularly minority older adults.
The REC will also develop and maintain a process for facilitating and tracking the evolution of scientists from
pilot to independent investigators, and evaluation of the REC, by collaborating with the National Coordinating
Center and participating in an annual reporting procedure. To accomplish the specific aims, the REC will
maintain the infrastructure necessary to recruit, develop, and support under-represented minority investigators.
This yields a more diverse biomedical workforce by building the capacity of a cadre of new investigators from
under-represented backgrounds who are committed to a research portfolio focused on health disparities and
minority aging research as it relates to AD/ADRD. This goal will be largely achieved by cultivating cutting edge
pilot studies that will lead to a greater understanding of health disparities in AD/ADRD, and AD/ADRD among
populations of under-represented groups.